Discovery of Immunogenomic Associations with Disease and Differential Risk Across Diverse Populations

ABSTRACT
Genetic variation in immune-related genes, as in the human leukocyte antigen (HLA) locus, plays a pervasive
role across organ systems. HLA variation, called HLA alleles, is used to match organ donors, and has been
associated with adverse drug reactions (ADRs), cancer, infections, and cardiovascular and neurologic diseases.
However, most studies focus on the impact of HLA variation on specific immune-mediated diseases; the broader
influence of HLA variation across all human disease has not been investigated in depth. The proposed research
program will address the challenge of identifying immunogenomic influence on a broad spectrum of diseases
and ADRs. Previous studies of HLA influence have almost exclusively focused on populations of European
descent, thus differences across ancestral groups are not well understood. The availability of the All of Us
Research Program (AoU), a large, diverse DNA biobank coupled to electronic health records (EHR) enables
investigation of how HLA alleles influence many diseases across multiple diverse populations simultaneously.
We propose to perform systematic investigation of the association of HLA alleles with disease, using a two
pronged approach based on the phenome-wide association study (PheWAS). PheWAS is a disease-neutral
approach that identifies the association between genetic variation across a broad set of diseases. In Specific
Aim 1, HLA alleles will be determined using whole genome sequence data, and PheWAS will be deployed in
AllofUs to determine the influences of HLA alleles across organ systems, and to explore ancestral differences in
HLA associations. We will determine association of HLA-A, -B, -C, -DR, and -DQ alleles with a comprehensive
set of diseases within and across major ancestry groups in AoU. Despite its power, PheWAS analysis is limited
to identifying single-allele connections to phenotypes of interest, so influences that result from HLA interactions
(either combinations of HLA alleles, or between an HLA gene and some other genomic context) may be missed.
Specific Aim 2 will address this shortcoming – we will develop Machine Learning strategies to explore the effect
of HLA allele interactions on disease, and explore the potential for recognizing pleiotropic influences of HLA
alleles. This innovative PheWAS-based approach has the potential to discover novel mechanisms of many
diseases, identify biomarkers that may predict disease, and create a roadmap by which future researchers
investigate the impact of HLA variation in human disease. As indicated by our previous work, PheWAS has the
potential to condense decades of immunogenomic discoveries into a single analysis. When applied to under-
studied, diverse populations, this work has the potential to accelerate this field of research. This approach can
be applied to many other genomic loci, differential associations by other characteristics such as sex and/or
gender, and identification of pleiotropic effects across disease systems, creating a number of potentially fruitful
avenues of future research.

Public health relevance
PROJECT NARRATIVE Immunogenomic variation plays a pervasive role across organ systems and is implicated in myriad conditions, including adverse drug reactions and infectious, oncologic, cardiovascular, and neurologic diseases. The proposed research is relevant to public health because it has the potential to accelerate genomic research on the biology of disease and create a model by which future researchers investigate the impact of immunogenomic variation. Thus, the proposed research is relevant to the part of the NIH mission that pertains to reducing the public health burden of a wide variety of disease and adverse drug reactions.